Identifying and characterizing human pulmonary neuroendocrine stem cells and their diversity

PROJECT SUMMARY
Pulmonary neuroendocrine cells (PNECs) are sensory epithelial cells that signal to the brain
through sensory neurons and locally through neuropeptides and neurotransmitters. We used
scRNA-seq to comprehensively profile and analyze mouse and human PNECs, which revealed
over 40 PNEC neuropeptides and hormones in diverse combinations. Here, we propose to map
the innervation and molecular subtypes of human pulmonary neuroendocrine cells and identify
the functional subsets in human lung, beginning with an investigation of functionally distinct
neuroendocrine stem cells. Using precision cut lung slice cultures to establish an injury model
inducing proliferation, we will identify the location of proliferative PNECs and measure their
complete transcriptomic profiles by scRNA-seq. In parallel, we will use multiplex single molecule
in situ hybridization methods to localize the human PNEC neuropeptides, identify their
combinations in situ, and their cognate receptors in human lung. Collectively, these studies will
comprehensively characterize the cellular and molecular features of human PNECs, their stem
cells and niches. PNEC expansions and ectopic pulmonary neuroendocrine cells are the
distinguishing pathologic features underlying a common form of pediatric diffuse lung disease,
neuroendocrine cell hyperplasia of infancy (NEHI), which is characterized by diffuse obstructive
ventilatory defect. In adults, a pre-neoplastic condition called diffuse idiopathic pulmonary
neuroendocrine cell hyperplasia (DIPNECH) is also associated with airway obstruction and
prominent respiratory symptoms thought to be due to bioactive peptides from neuroendocrine
cells. We will identify the neuropeptide and receptor expression in pathological cell niches
during NE stem cell transformation in DIPNECH. This work establishes a molecular foundation
for the diverse clinical presentations associated with pulmonary neuroendocrine lesions and
identifies panels of neuropeptides and hormones localized to precise anatomic locations that will
provide the basis for developing novel diagnostic and therapeutic approaches.

Public health relevance
PROJECT NARRATIVE Our comprehensive analysis of the rare, but physiologically important pulmonary neuroendocrine cells, identified myriad combination of neuropeptides, neurotransmitters, receptors, and channel genes in individual pulmonary neuroendocrine cells (PNECs), indicating PNECs serve as sentinels to perceive multiple airway stimuli and express a variety of signals that regulate homeostasis. Achieving the aims of this proposal will identify the locations of cells expressing human PNEC peptides and hormones, their expression patterns in neuroendocrine stem cells, and their cellular targets in human tissue. This work is fundamental to developing new treatments and diagnostic strategies across the spectrum of pediatric and adult lung neuroendocrine diseases.